IGF::OT::IGF DEVELOPMENT OF WEB-BASED EDUCATIONAL MODULES ON THE 2017 SOLID TUMOR MULTIPLE PRIMARY AND HISTOLOGY CODING RULES

DEVELOPMENT OF WEB-BASED EDUCATIONAL MODULES ON THE 2017 SOLID TUMOR MULTIPLE PRIMARY AND HISTOLOGY CODING RULES